Recovery of symptoms, function, tendon structure and mechanical properties in patients with Achilles Tendinopathy: A comparison between men and women

Project Summary/Abstract
Achilles tendinopathy has an incidence rate of 2.35 per 1000 in the general population and is most prevalent in
middle-aged individuals (35-55 y/o), but occurs in men and women of all ages. The primary symptom is pain
during daily activities such as walking and exercising such as running. Aside from the pain, Achilles tendinopathy
has been shown to significantly decrease physical activity level, resulting in further negative effects on overall
health and well-being. The treatment for Achilles tendinopathy with the highest level of evidence is eccentric
exercise, providing mechanical loading of the muscle-tendon unit. In a recent systematic review, all studies
reported significant improvements in patient-reported symptoms but at 12 weeks the means ranged from 69-80
(100 being fully recovered) indicating that even with the most effective treatment individuals continued to have
symptoms. At this time, other more invasive interventions such as injection therapies (ex. platelet-rich plasma)
and surgery are recommended for patients who fail exercise treatment despite a lack of understanding of what
factors are related to continued problems. Just achieving a reduction in pain and symptoms with treatment also
does not ensure resolution of the tendon's structural abnormalities. In fact, studies evaluating the recovery of
tendon structure with exercise suggest that at least 24 weeks may be needed to observe a significant change.
Other individual factors such as sex, degree of tendon structural damage and functional deficits are also proposed
to influence both the time course and success rate of recovery. The long-term goal of our research is to advance
understanding of tendon injuries and repair, enabling tailored treatments to be developed. This study begins to
address this long-term goal by evaluating the time-course of recovery in terms of tendon structure (ultrasound
imaging) and viscoelastic properties (elastography) along with symptoms (patient-reported outcomes) and
muscle-tendon function (functional test-battery) in men and women with Achilles tendinopathy treated with an
exercise program. Aim 1 is to evaluate if there are differences in change over time in symptoms, muscle-tendon
function, tendon structure, and mechanical properties between males and females with Achilles tendinopathy
receiving exercise treatment. Aim 2 is to investigate whether the presence and magnitude of tendon structural
abnormality at baseline will affect the ability and time-course of recovery with exercise treatment for Achilles
tendinopathy. Aim 3 is to explore if patients who continue to have symptoms at the 16-week evaluation will
further improve in symptoms, muscle-tendon function, tendon structure and mechanical properties over the
course of one year. This study will be the first to evaluate if there is a difference in recovery of tendon structure
and mechanical properties between males and females with Achilles tendinopathy receiving exercise treatment.
It will also be the first study to evaluate recovery of tendinopathy with exercise intervention using outcome
measures for tendon structure and mechanical properties along with validated measures of muscle-tendon
function and symptoms.

Public health relevance
Project Narrative This study will be the first to evaluate if there is a difference in recovery of tendon structure and mechanical properties between men and women with Achilles tendinopathy receiving exercise treatment. It will also be the first study to evaluate recovery of tendinopathy with exercise intervention using outcome measures for tendon structure and mechanical properties along with validated measures of muscle-tendon function and symptoms. The results from this study will play a critical role in understanding how to achieve full tendon recovery (if possible) and optimize treatment for patients with tendinopathy.